Palliative Care Research Cooperative Group (PCRC): Data, Informatics and Statistics Core

PROJECT SUMMARY/ABSTRACT
The primary goals of the U2C application are to increase the productivity and impact of the Palliative Care
Research Cooperative Group (PCRC) through facilitating the conduct of high-quality, effective clinical research
and expanding the number and expertise of palliative care researchers in conducting multi-site clinical trials. In
pursuit of these overall goals and objectives, the Data, Informatics and Statistics Core (DISC), one of four
Cores within the PCRC, strives to serve as a resource for the design of statistical analysis plans for multi-site
clinical trials and to provide quantitative and/or qualitative biostatistical support to the majority of multi-site
clinical trials and data-analysis projects using PCRC resources. The DISC's specific aims are: (1) to facilitate
collaborative, rigorous, multi-site, EOLPC research studies by providing resources pertinent to the design and
analysis of all stages of research ranging from formative to clinical trials; (2) to expand the PCRC Data
Repository, a warehouse of both qualitative and quantitative data from PCRC funded and supported studies
and other EOLPC research studies, to facilitate secondary data analyses; (3) to collaborate with the other
PCRC Cores (Measurement; Caregiver Research; and Clinical Studies/Methodology) and Centers to
accomplish the overall Specific Aims of the PCRC and the Core and Center specific aims; and (4) to work with
the Investigator Development Center (IDC) to educate and mentor PCRC investigators in statistical methods
and study design. Rigorous palliative care research cannot exist without a solid statistical foundation. The
DISC undertakes diverse set of tasks that are both topically-specific to the mission of the Core and interrelate
and integrate with the other PCRC Centers and Cores. The DISC serves as a catalyst to expand the capacity
of the PCRC to better quantify and understand the impact of serious illness and treatments on the health,
quality of life, and end-of-life trajectory of patients and caregivers through rigorous study design, conduct and
data capture/analysis.